DIET. FATTY ACIDS ON ENERGY BAL. AND BLOOD PRESSURE IN HYPERTENSIVES

This project involves assessing the effects of type of dietary fat on blood pressure, determinants of blood pressure, and energy balance in obese, hypertensive subjects during a weight reduction diet.